A lipid signaling network through stearoyl Co-A desaturase regulates hepatocellular carcinogenesis through YAP/TAZ activity

Nonalcoholic fatty liver disease (NAFLD)-associated hepatocellular carcinoma (HCC) is the fastest growing
cause of HCC and predicted to become the leading indication for liver transplantation. As liver transplantation
remains a scarce resource, chemoprevention and early treatment are imperative. NAFLD patients represent a
distinct high-risk population due to the challenges of HCC screening related to obesity, potential absence of
elevated tumor markers, and the observation that 20-30% of cases occur in the absence of cirrhosis, who are
not targeted for screening. Given that early detection is key in improved survival and receipt of curative treatment,
understanding the mechanisms leading to NAFLD-related HCC have important clinical consequences. Although
lipophilic statins have been associated with decreased HCC incidence, their chemo-preventative mechanism(s)
remains elusive. Over the years, the YAP/TAZ cascade emerged as an important signal transduction pathway
in the pathogenesis of HCC, and has been shown to be modulated by changes in intracellular lipids. Stearoyl-
CoA desaturate (SCD), the rate limiting enzyme of monounsaturated fatty acids (MUFAs), is a key enzyme in
the Hippo pathway that links YAP/TAZ to sterol regulatory element binding protein 1 (SREBP1) and mTORC1 in
hepatocarcinogenesis. Using human liver bulk RNA sequencing studies of a prospective cohort of NAFLD/NASH
patients undergoing bariatric surgery, we discovered a novel regulatory role of SCD by a long non-coding
enhancer RNA. After characterizing the intracellular lipid pool with an SCD inhibitor, we next investigated the
role of SCD on the YAP/TAZ pathway using an in vitro cell culture model and demonstrate SCD-dependent
decrease on YAP protein and its target genes. Our preliminary data led us to hypothesize that SCD and
monounsaturated to saturated fatty acid ratios regulate and are a point of convergence in the YAP/TAZ,
mTORC1 and mevalonic acid pathways. In this proposal, we aim to delineate the mechanisms underpinning the
role of lipids in HCC through the YAP/TAZ pathway. In Aim 1, we will study cellular sub-types in HCC and
adjacent non-HCC human samples to identify how the YAP/TAZ pathway relates to lipid gene expression. Gene-
environment interactions with statin use will also be investigated using the Million Veteran Program, to identify
the sub-group of patients who would benefit from statin chemoprevention. In Aim 2, we test the hypothesize that
statins and the mevalonic acid pathway regulate YAP/TAZ function through Rho in hepatocytes and patient-
derived tumoroids. The effects of statin on cellular localization and phosphorylation of YAP/TAZ and the
YAP/TEAD-regulated genes will be examined. We will determine if these effects are dependent on Rho or
intracellular cholesterol/lipid metabolites. In Aim 3, the role of SCD on the regulation of YAP/TAZ, cell proliferation
and migration in a panel of hepatocytes and cancer cells will be examined. These studies will lead to further
understanding of the mechanisms of lipophilic statins and other lipid-modulating agents in chemoprevention and
identifying YAP/TAZ HCC cellular signatures, with the goal of advancing precision oncology in Veterans with
NAFLD-HCC. The training objectives in this proposal will foster Dr. Benhammou’s growth as a translational
cancer researcher, which are made possible by a rich scientific environment at the University of California, Los
Angeles and the VA Greater Los Angeles.

Public health relevance
Nonalcoholic fatty liver disease presents a significant burden for the VA Healthcare System and hepatocellular carcinoma is among its most consequential complication. Because the underlying mechanism(s) of the development of hepatocellular carcinoma in patients with nonalcoholic fatty liver disease are poorly understood, treatment and chemoprevention options are lacking. In this proposal, we will study the effects of lipid pathways, including statins, on the emergent YAP/TAZ oncogenic pathway in hepatocellular carcinoma. We will test the hypothesis that treating normal and cancer cells with a combination of lipid-modifying agents and mTORC1 targets (part of the YAP/TAZ pathway) will affect cell growth and proliferation. Thus, the most translatable outcomes of the findings from this proposal could be the identification of chemoprevention methods and therapeutic targets important in the progression of nonalcoholic fatty liver disease to hepatocellular carcinoma.